Discovery of T-type Calcium Channel Antagonists from Multicomponent Reactions and Their Application in Paclitaxel-induced Peripheral Neuropathy

Summary Abstract Chemotherapy-induced peripheral neuropathy (CIPN) is detected in 64% of cancer patients during all phases of cancer. Sensory symptoms in the hands and/or feet, typically in a “stocking-glove” pattern, are common, and manifested as pain, numbness, and/or tingling. CIPN can result in chemotherapy dose reduction or discontinuation, and can also have long-term effects on the quality of life. The course of CIPN can be unpredictable: while symptoms may resolve after chemotherapy is discontinued, they can also continue for years. Since its introduction in the 1970s, the antimicrotubule Paclitaxel (Taxol®) has been used as an effective anticancer agent against lung, breast, ovarian, leukopenia and liver cancer. But, Paclitaxel-induced peripheral neuropathy is the major dose-limiting side effect of paclitaxel. Taxanes (like Paclitaxel) may cause structural damage to peripheral nerves, resulting in aberrant somatosensory processing in the peripheral and/or central nervous system. Dorsal root ganglia (DRG) sensory neurons as well as neuronal cells in the spinal cord are key sites in which chemotherapy induced neurotoxicity occurs. Pathogenesis is complex but includes dysregulation of ion channels. For example, Paclitaxel increases expression of low-voltage activated T-type (Cav3.2) Ca2+ channels in rat DRG neurons; these neurons are responsible for conveying noxious sensory stimuli, suggesting these channels are important mediators of specific sensory abnormalities associated with CIPN. T-type Ca2+ channels are critical determinants of increased neuronal excitability and neurotransmission accompanying persistent neuropathic pain. Though Cav3.2 has been targeted clinically with small molecule antagonists, no drugs targeting these channels have advanced to phase II human clinical trials. This proposal aims to explore multicomponent reaction products, developed in the laboratory of the PI - Dr. Jun Wang, for the rapid identification of potent and selective T-type Ca2+ channel antagonists. For this work, we have partnered with Dr. Rajesh Khanna (PI and Chief Scientific Officer, Regulonix, LLC) for characterizing select compounds and their analogs in in vitro and in vivo efficacy assays as well PK optimization. The work proposed here is the first step in developing non-opioid pain treatments for CIPN. We anticipate success against paclitaxel-induced chronic pain will translate into other chronic pain types as well, but CIPN provides focus for early stage proof-of-concept. Regulonix's specific aims are: (1) Design and synthesis of UAWJ111 analogs and elucidation of channel specificity and biophysical properties of select UAWJs to gain mechanistic and safety information and to document the unique pathway for function in relevant neuronal cells; (2) Profile the in vitro cellular cytotoxicity and pharmacokinetic properties of UAWJ111 analogs; (3) Characterize the best two UAWJs, from Aim 2, for preclinical studies using a neuropathic pain model (paclitaxel) to provide information about efficacy. At the conclusion of our study, we expect to have a validated UAWJ analog and several worthy backup compounds.

Public health relevance
Narrative Chemotherapy-induced peripheral neuropathy (CIPN) is detected in 64% of cancer patients during all phases of cancer, for which there is no effective treatment at the moment. To address this unmet medical need, we propose to develop potent and selective T-type Ca2+ channel antagonists as novel pain medicines for the management of CIPN. Successful execution of this proposal is expected to provide pain relief to cancer patients, increase their compliance of chemotherapy, and improve their well-being.